Stereospecific Cross-Coupling Reactions as a Tool for Three Dimensional Molecular Diversification

PROJECT SUMMARY/ABSTRACT
Using enantioenriched organometallic nucleophiles in transition metal-catalyzed carbon-carbon
bond-forming reactions, we aim to develop general tools for the rational manipulation of three-
dimensional molecular structure. By introducing absolute stereochemistry prior to the formation
of a final stereogenic center, and reliably transferring this stereochemistry via stereoretentive or
stereoinvertive cross-coupling processes, the rapid preparation of diverse libraries of single-
enantiomer drug candidates for use in biological assays will be achievable. The use of
enantioenriched secondary alkylboron and alkylstannane nucleophiles will be explored in Pd-
and Cu-catalyzed alkyl-aryl and alkyl-alkyl cross-coupling reactions, with particular focus on the
derivatization of medicinally relevant organic frameworks and chiral structural motifs that are
currently inaccessible but are of biological or pharmaceutical interest.

Public health relevance
Project Narrative Our proposed research focuses on the development of general methods to modify the three-dimensional structure of organic molecules, which will expedite preparation of diverse libraries of biologically active molecules for testing as drug candidates. We aim to devise new drug discovery techniques that permit rapid access to common, high- demand molecular architectures predictably, safely, and inexpensively.